Promoting Safety by Engaging Diverse Diabetes Patients and their Caregivers in Secure Messaging

Project Summary/Abstract
Dr. Wagahta Semere’s long-term career goal is to be an independent clinician-investigator and leader in
developing and implementing technology-based communication interventions to engage caregivers for diverse
patients in effective and safe chronic disease care. She has identified engaging caregivers in diabetes
management as a critical issue to achieve this goal. This proposal describes her comprehensive 5-year
program of training and mentored research. The work proposed is aligned with AHRQ’s Division of Digital
Healthcare Research mission to explore how the evolving digital healthcare ecosystem can best advance the
quality, safety, and effectiveness of healthcare for patients and their families and addresses several AHRQ
Priority Populations (women, elderly, racial/ethnic minorities, low income, and chronic illness groups). While Dr.
Semere has a strong background in health services research, this K08 will provide key training in large data
analytics, qualitative and mixed methods research, and implementation science. Communication in chronic
illness care that leads to shared understanding has been linked to improved adherence, better disease control,
and safer outcomes. Patient portals—systems that allow patients convenient access to their health information
online and the ability to exchange secure messages (SM) with providers—offer an ideal communication
platform to achieve shared understanding and better outcomes in type 2 diabetes (T2D). Caregivers acting as
proxies, messaging on patients’ behalf, can enable and expand the ability of patients to engage with providers
via SM platforms. Yet, proxies largely remain an untapped resource, especially for racial/ethnic minorities and
those with communication barriers, who may benefit most from proxy involvement. The proposed specific aims
are (1) to determine the independent effect of patient use of caregiver proxies for secure messaging (SM) on
clinical outcomes among T2D patients with and without proxies, (2) to compare the characteristics of SM
exchange between T2D patients and their PCPs among patients who do and do not use caregiver proxies, and
(3) to develop and test a pilot intervention in the safety-net setting to engage caregivers in SM to promote
effective communication and safe disease management for T2D patients. Dr. Semere’s mentorship team is led
by Dr. Schillinger and includes nationally recognized health services researchers, communication scientists,
qualitative and mixed methods experts, and implementation scientists who together will provide practical
guidance to complement her didactic training. In addition, the supportive research environments at UCSF and
within the Division of General Internal Medicine at Zuckerberg San Francisco General, will enable her to
achieve the proposed project aims. Upon completion of the proposed research and training, Dr. Semere will
submit a competitive R-level grant application to test the pilot intervention in a randomized trial across several
safety-net clinics. She will possess the skills and experience to make impactful contributions to patient quality
and safety in chronic disease through evidence-based and family-centered communication interventions.

Public health relevance
Project Narrative Secure messaging (SM) via patient portals is an effective health IT platform that can enable patients and providers to reach shared understanding, an intermediate communication outcome, which has been linked to improved adherence, better disease control, and safer outcomes. For patients with communication barriers, advanced age or severe illness, SM also has potential to engage caregivers in facilitating patients’ ability to reach shared understanding with their healthcare providers. The goal of the research proposed in this career development award is to (a) understand the value and attributes of caregiver involvement in SM exchange between diverse T2D patients and their providers, and (b) apply this knowledge to develop a pilot portal intervention in the safety-net targeting diverse T2D patients (at high risk for hypoglycemia, a patient safety event) and their caregivers to promote shared understanding and safety.